Waters Synapt XS Mass Spectrometer for Louisiana State University

Project Summary
This proposal requests funding for a Waters Synapt XS mass spectrometer that will support
biomedical research at Louisiana State University. The instrument will be placed in the LSU
Department of Chemistry Mass Spectrometry Facility. The Mass Spectrometry Facility is currently
the only user facility on the LSU campus where mass spectrometry-based metabolomics and other
analysis to support NIH investigators. The acquisition of the proposed instrument will allow
researchers at LSU to conduct metabolomics experiments for which they are currently dependent
on outside facilities. This will allow NIH-funded PIs to conduct a larger portion of their
experiments directly at LSU, which allows for overall more efficient research. Acquisition of a
metabolomics-oriented mass spectrometer will complement the current portfolio of mass
spectrometry instrumentation and provide a comprehensive platform for basic and translational
research that is at the center of the biomedical research mission of the university. Acquisition of
the Waters Synapt XS mass spectrometer will provide a resource that is currently available to LSU
biomedical researchers and enable them to expand the scope and efficiency of their work.

Public health relevance
Project Narrative Acquisition of the Waters Synapt XS mass spectrometer will support the research of a diverse group of biomedical researchers Louisiana State University in the College of Science, Agricultural Center, and the School of Veterinary Medicine. The instrument will support research aimed biomedical research across the Baton Rouge LSU campus. The acquisition of the proposed instrument will allow researchers from multiple units to conduct metabolomics experiments for which they currently dependent on outside facilities.